Osmotic Stress Sensing and Signal Transduction in Arabidopsis

PROJECT SUMMARY
Hyperosmotic stress has been linked to several human diseases. Furthermore, drought-linked
hyperosmotic stress is of major concern for threatening human nutrition and health. However, these
osmotic/drought stress sensors and the early osmotic stress signal transduction mechanisms have
remained largely unknown. Hyperosmotic stress triggers rapid intracellular Ca2+ transients in Arabidopsis.
Moreover, we have recently discovered rapidly-activated Raf-kinases that are required for early
hyperosmotic stress signal transduction in Arabidopsis. These early signal transduction mechanisms are
required for resistance mechanisms, including downstream biosynthesis of the stress resistance
hormone abscisic acid. Rapid osmotic stress responses in the highly developed Arabidopsis model
organism provide an ideal system for dissection of a eukaryotic osmotic stress sensing and signal
transduction machinery. The long-term objective of this research program is to achieve a molecular,
cellular, mechanistic and quantitative understanding of osmotic stress sensing and signal transduction in
the genetically tractable Arabidopsis model system.
We will address the question of the unresolved osmotic stress sensor machinery and signal
transduction cascade, through an innovative screen and new mutants we have isolated that greatly impair
the rapid osmotic stress-induced Ca2+ transients. Moreover, downstream of hyperosmotic stress, we have
recently found osmotic stress-triggered genome-wide chromatin remodeling that correlates with osmotic
stress-induced transcriptome responses. The question of how osmotic stress signal transduction links to
and mediates osmotic stress-induced genome reprogramming will be pursued. Furthermore, the question
whether osmotic stress-induced chromatin remodeling primes the genome for future stress resistance
will be investigated and underlying mechanisms will be determined. Another question of particular interest
is how guard cells rapidly close stomata in response to low humidity (high vapor pressure difference),
thereby reducing water loss. This elusive cellular low-humidity sensing and signal transduction pathway
has been hypothesized to be related to osmotic stress sensing and signaling. We have recently
discovered Raf-kinases, overlapping with the above-mentioned hyperosmotic stress-activated Raf-
kinases, and a transmembrane receptor like pseudo kinase that are required for the rapid low humidity
response in guard cells, providing a foothold for dissecting the underlying molecular and cellular signal
transduction pathway. My laboratory applies diverse cellular signaling, genetic, genomic, biophysical and
time-resolved imaging approaches to address fundamental questions in stress sensing and signaling.
Results from this research will illuminate the elusive osmotic/drought and humidity sensing and signaling
mechanisms and could lead to future strategies for improving food security for human health and nutrition.

Public health relevance
PROJECT NARRATIVE Cells, organs and organisms are to a great extent susceptible to osmotic stress caused by unbalanced water content or dehydration, with hyperosmotic stress having been linked to several human diseases. This research program will make use of a powerful unbiased genetic screen and time-resolved signal transduction analyses to dissect molecular and cellular mechanisms mediating hyperosmotic and dehydration stress sensing and signal transduction. This research will leverage an easily manipulated and highly developed model system to develop an in-depth understanding of eukaryotic osmotic stress response mechanisms.